Allele Specific Knockdown for LGMD-D1

PROJECT SUMMARY
Gene-based therapies are becoming a reality for disabling neuromuscular disorders. However, the limb girdle
muscular dystrophy (LGMD) gene therapy field is focused almost entirely on recessively inherited disorders,
leaving dominantly inherited LGMDs far behind in the path towards a cure. Recently mutations in DNAJB6, an
HSP-40 co-chaperone, were discovered to cause LGMD-D1, an adult onset, dominantly inherited myopathy.
The disease mechanism behind LGMD-D1 is incompletely understood, preventing therapeutic strategy
development. Addressing this unmet medical need will help us better understand not only how to treat LGMD-
D1, but also how to efficiently approach therapeutic strategy development for other dominantly inherited
myopathies. Dominant myopathies are known to have complex, heterogenous disease mechanisms, including
toxic gain of function, dominant negative, and haploinsufficiency. Each requires a unique therapeutic approach,
such as global knockdown, allele specific knockdown (ASKD), knockdown and replace, or simply gene
replacement in the case of haploinsufficiency. Several lines of evidence indicate mutations in DNAJB6 exert a
dominant effect through a toxic gain of function. Additionally, DNAJB6 knockout (KO) mice are embryonic
lethal due to aggregation of client proteins, indicating a global knockdown treatment may be deleterious.
However, haploinsufficiency appears to be tolerated as heterozygous KO mice are viable and able to breed.
Targeted knockdown of the mutant allele is therefore an ideal LGMD-D1 treatment strategy to address the
toxic gain of function mechanism, while avoiding the damaging effects of complete DNAJB6 knockout. This
proposal aims to validate ASKD has therapeutic potential for LGMD-D1. As several siRNAs are now FDA
approved, this project will optimize siRNAs to achieve ASKD of mutant DNAJB6 (aim 1), and validate whether
ASKD improves disease phenotypes in mouse and human LGMD-D1 models (aim 2). Foundational to these
studies, is a knock-in LGMD-D1 mouse model containing a flag tag on the wild type allele, allowing for size-
based detection of allele specific changes. Successful completion of these studies will identify a therapeutic
target for LGMD-D1, which will in turn, also provide additional insights into disease mechanism. LGMD-D1 is
only one of several disorders that may be amenable to the strategies described in this proposal.

Public health relevance
Project Narrative The limb girdle muscular dystrophy (LGMD) gene therapy field is focused almost entirely on recessively inherited disorders, leaving dominantly inherited LGMDs far behind in the path towards a cure. This project aims to develop allele specific knockdown using siRNAs as a therapy for LGMD-D1, an adult onset dominantly inherited myopathy, lacking any treatments. LGMD-D1 is only one of several disorders amenable to the treatment strategies described in this proposal.